APPLICATION OF GENETIC ALGORITHMS TO OPTIMIZATION OF ESEEM DATA STIMULATION

We are applying Genetic Algorithm techniques to achieving automatic optimization of simulations of ESEEM data. We use the methods of Meyer, et al. (Phys. Rev. Lett 63:1735, 1989) and Rodriguez, et al. (J. Phys. Chem. 100:6849, 1996) in a novel application to ESEEM spectroscopic data from 2-, 3-, and 4-pulse experiments.